HeartShare DeCODE-HF: Data translation center to Combine Omics, Deep phenotyping, and Electronic health records for Heart Failure subtypes and treatment targets

PROJECT SUMMARY
The Overarching Aim of the Northwestern HeartShare DeCODE-HF: Data translation center to Combine
Omics, Deep phenotyping, and Electronic health records for Heart Failure subtypes and treatment
targets is to provide overall management and oversight for HeartShare, including coordination and
communication across all subsections and cores of the program, and with the 4 HeartShare Clinical Centers
(CCs). The Data Translation Center (DTC) will need to ensure timely completion of the retrospective and
prospective components of HeartShare. In our application, we demonstrate the ability and prior experience of
our multi-PI team and core leaders in the conduct and leadership of large-scale, multi-center studies, particularly
in the realms of heart failure with preserved ejection fraction (HFpEF), electronic health record (EHR)-based
investigation, deep phenotyping, machine learning, and biorepositories. For both the retrospective and
prospective HeartShare components, the Northwestern DTC will leverage its considerable experience in: (1)
cohorts and trials that have data on adjudicated HF patients, and (2) its leadership and track record as the top
enroller in HFpEF trials/studies to ensure optimal recruitment by the HeartShare CCs. We will also leverage our
expertise in HFpEF, data coordination/management, BioData Catalyst, EHR-based research, biostatistics,
machine learning, multi-omics, human-computer interaction, and mobile health data monitoring to (1)
successfully execute the HeartShare program and (2) meet the HeartShare DTC goals of providing a rich
resource to the research community to advance the science of next-generation phenomics to identify HFpEF
subtypes and therapeutic targets. Our HeartShare DTC will carry out each of its 4 primary responsibilities. (1)
The Administrative and Outreach Core will oversee HeartShare program operations, research skills
development, and capitation to CCs for deep phenotyping costs; support a call center to follow patient outcomes;
and promote rapid and broad data-sharing of clinical and molecular data. (2) The Data Portal Core will serve as
the primary access point (via a web-based interface) and coordinating center for all HeartShare data; and to
develop an interactive patient-facing web-based interface for remote consent, completion of forms, and collection
of mobile health data using BioData Catalyst tools. (3) The Data Management Core will oversee ensure data
quality, integration and harmonization of various data types; perform advanced analytics; coordinate
biospecimen and imaging biorepositories; and integrate with TOPMed for omics analyses. (4) The Cohort Core
will aggregate data on HF patients from completed epidemiology cohorts and HF trials and will combine data
with further bioprofiling of existing samples to allow discovery/validation of novel targets.

Public health relevance
PROJECT NARRATIVE The Northwestern HeartShare Data Translation Center will provide overall management and oversight of the HeartShare program via 4 cores, including an Administrative/Outreach, Data Portal, Data Management, and Cohort cores. By providing an expert investigative team and complementary areas of expertise, the HeartShare Data Translation Center will achieve the primary goals of HeartShare: (1) to develop a rich resource for the scientific investigators for the detailed study of heart failure; and (2) to advance the science of identifying novel heart failure subtypes to promote a tailored, precision medicine approach to heart failure patients in order to reduce morbidity and mortality.